Impact of Sex on Prenatal Stress-Immune Programming of Depression and Autonomic Dysregulation

PROJECT 1 SUMMARY. Major depressive disorder (MDD) topped ischemic heart disease as the number one
cause of disability worldwide, and women have twice the risk of men. Although this is well-known, even recent
studies of brain circuitry and genes associated with mood dysregulation and MDD per se do not investigate sex
effects nor incorporate even current sex-dependent knowledge into development of therapeutics. This is
surprising since MDD is associated with abnormalities in stress response circuitry including hypothalamus
(HYPO), amygdala (AMYG), hippocampus (HIPP), anterior cingulate cortex (ACC), and ventromedial and
orbital prefrontal cortices (vmPFC, OFC), areas that are among the most sexually dimorphic in the brain. HIPP,
HYPO, AMYG, and PFC are dense in sex steroid and glucocorticoid receptors coupled with cytokine receptors,
in particular, TNF-α, IL-1β, IL-6, the major co-activators of the hypothalamic pituitary adrenal (HPA) axis. In
fact, activity in these areas has been associated with cortisol response, autonomic dysfunction characterized
by loss of parasympathetic cardiac tone, and immune responses, which we previously showed differed by sex.
Furthermore, autonomic dysregulation is significantly associated with cardiovascular disease itself, with women
at twice the risk of the co-occurrence of MDD and heart disease, leading to a 3-5-fold risk of death in women
from heart disease, often with unrecognized and untreated MDD. This is a worldwide public health challenge,
and thus understanding early biomarkers for the co-occurrence later in life will provide knowledge to intervene
earlier. Leveraging a rare opportunity to investigate fetal antecedents to sex differences in adult MDD and
associated impact on central and peripheral physiology in early midlife in human in vivo studies, we will test
here that immune pathway abnormalities, beginning in fetal development, are associated with sex-dependent
impacts on HYPO, HIPP, AMYG and PFC, resulting in lifelong recurrent MDD (rMDD), and dysregulation of
hormone and immune responses to stress and autonomic dysfunction in early midlife. Adult subjects from our
prenatal cohort, for whom prenatal sera are archived and who have been included in our follow-up studies for
60 years, will be re-recruited (80 cases with rMDD/50 healthy controls, equally divided by sex, now ages 55-
61) for the proposed study. We will test whether these prenatal immune biomarkers are associated with lifelong
MDD and ANS and neurovascular dysregulation in early midlife (including structural and functional brain
abnormalities in stress response circuitry, physiologic dysregulation) and neurovascular dysfunction. We
predict that the sex differences in early midlife will be mediated by major depression in earlier adulthood, which
we predict is associated with sex-selective dysregulation of innate immunity resulting from maternal prenatal
exposure. Novel transcriptomic analyses of innate immunity genes will provide clues to immune pathways to
sex differences in MDD and autonomic dysregulation. Our lifespan perspective is an innovative approach that
will identify potential therapeutic sex-dependent targets for early intervention to attenuate disability later in life.

Public health relevance
Project 1 NARRATIVE. Women are at twice the risk of the co-occurrence of MDD and autonomic dysregulation, that is associated with a 3-5-fold risk of death from heart disease, often with unrecognized and untreated MDD. This study will investigate fetal stress-immune antecedents to sex differences in adult MDD, mood circuitry in brain, and associated impact on centrally driven cardiac physiology in early midlife. Identifying early biomarkers for the co-occurrence of MDD, autonomic dysregulation and frank heart disease later in life will provide knowledge to intervene earlier.